GASP--A SOFTWARE TOOL FOR METHODOLOGIC DEVELOPMENT IN STATISTICAL GENETICS

Development of computer software for statistical genetic analysis can be facilitated by the availability of software tools that can be used to 1) verify the algorithms, 2) determine empirical type I error rates, 3) determine the power of a test, and 4) to determine the robustness of a test with respect to failures of underlying assumptions. The Genometric Analysis Simulation Program (G.A.S.P.) is a software tool that can generate samples of family data based on user-specified models. Both trait and marker data can be generated. Data generated can be as simple as a single sample of random individuals, or as complex as thousands of samples of extended families with traits based on a linear combination of major locus, polygenic, common sibship environment and covariate components.